Reducing Metal Artifacts in Clinical X-Ray CT via Image Reconstruction Techniques

Title: Reducing Metal Artifacts in Clinical X-Ray CT via Image Reconstruction
Techniques
Abstract:
Metallic implants such as dental fillings, surgical clips, coils, wires, and orthopedic hardware
inside the patient body are very helpful in providing patients with better health benefits. On the
other hand, they may cause artifacts in many medical imaging modalities such as in x-ray CT
and MRI. Even though significant advances in both hardware and software have been made
over the years, metal artifacts in x-ray CT scans are still troublesome. The metal artifacts
appear as dark shadows and bright streaks. These artifacts, if not corrected, can severely
degrade the image quality and decrease the diagnostic value of the clinical examination.
X-ray generation in an x-ray tube is very inefficient; the efficiency is much less than 1%. A
high photon count requirement results in the acceptance of a wide energy spectrum, which is
contributed by both Bremsstrahlung and characteristic radiation. Metallic objects inside the
patient body can cause photon starvation and beam hardening. These effects are nonlinear and
difficult to establish an exact mathematical model for them. One of the state-of-the-art remedies
is to use the dual-energy CT to measure two sets of projections, and then by using a
mathematical model and combining these two data sets to estimate a set of synthetic
monoenergetic x-ray measurements. Another one of the remedies is the use of a metal artifact
reduction (MAR) algorithm that replaces the corrupted projection measurements in the detector
with interpolation from neighboring uncorrupted projections. In data starvation situations, the
dual-energy methods are not effective. The current MAR algorithms are still immature, and they
may create new artifacts while trying to suppress the metal artifacts.
This is a renewal application of our previous R15 grant entitled “Fast and Robust Low-Dose
X-Ray CT Image Reconstruction,” in which we have successfully developed image
reconstruction algorithms to combat noise. Some of our ideas formed during the last three years
can be further advanced into new ideas for metal artifact reduction in x-ray CT. In this R15
renewal, we will focus on new metal artifact reduction (MAR) algorithm development based on
conventional single-energy data acquisition. The innovation is the new way to set up the
objective functions for optimization. The uniqueness of our objective functions is that they do not
have a data fidelity term; they only contain the Bayesian terms. The Bayesian terms are formed
from the metal artifact features. A gradient descent algorithm is used to optimize the objective
functions and a new set of un-corrupted measurements are estimated. The final image is
reconstructed by the filtered backprojection (FBP) algorithm.
The proposed algorithms are cost-effective. We hypothesize that the proposed methods will
be more effective than the state-of-the-art MAR methods available for commercial CT scanners.
This hypothesis will be carefully evaluated in this renewed R15. Our clinical collaborators at
University of Utah HealthCare will work with us closely by providing us clinical data and
professional evaluation advice.
This R15 project provides Utah Valley University (UVU) students with hands-on
opportunities and experiences of performing real-world research in the field of healthcare. It will
stimulate the interests of students so that they consider a career in biomedical and
bioengineering field/industry.

Public health relevance
Narrative: Metal artifacts in x-ray CT greatly degrade the image quality for clinical diagnosis. Current state-of-the-art metal artifact reduction methods are still immature, and improvements are urgently needed. The proposed research will focus on developing image reconstruction methods that are able to further reduce CT metal artifacts without increasing the CT scanner’s hardware complexity.